Pathogenic Exosomes in COPD

PROJECT SUMMARY
The thesis of this R35 Program is that immune cell derived “pathogenic exosomes” are
key players in chronic obstructive pulmonary disease (COPD) and that their role can be
modeled in a smoking mouse model of exosome transfer to attain novel understanding of the
disease which can in turn be applied to COPD. This R35 Program is at the cutting edge of
innovation having discovered the existence of alpha-1 antitrypsin (α-1AT) resistant neutrophil
elastase (NE)+ neutrophil (PMN)-derived exosomes in COPD patients. In doing so, the Program
has challenged the concept that protease activity is solely solution phase and shown
extracellular matrix (ECM) proteolytic activity is hugely enhanced by protease attachment to the
extracellular vesicle (EV) surface. Consequently, we: i) describe what appears to be the first EV
that can transfer a COPD-like phenotype from humans to mice; ii) elucidate a new mechanism
by which proteases escape anti-protease inactivation, leading to ECM degradation and cell
death via receptor-interacting protein kinase 3 (RIPK3); iii) describe a new model that transfers
a COPD phenotype from cigarette smoke (CS) exposed mice to naïve mice via immune cell-
derived exosomes; iv) use the mouse model to discover a new CS induced protective
mechanism against exosomal damage as well as a mechanism for exosomal self-propagation;
v) uncover new therapeutic targets for exosomal damage and; vi) translate the new findings to
better understand disease in COPD patients and smokers.
Another highly significant aspect of this research Program is training/mentoring. In the
past ten years, which includes the PI's inaugural R35 grant, the PI has been or is currently
mentor to two PhD students, five medical students, an MD/PhD student, six K awardees, four
postdoctoral trainees, a pulmonary fellow, and a cardiology fellow. The PI currently mentors
seven junior faculty members. Overall, our Program is both multidisciplinary – employing
chemistry, biochemistry, molecular and cell biology, animal physiology, etc. – and translational
in pairing basic scientists with physician scientists. Our team and trainees fulfill the NHLBI/NIH
mission to have diversity by including African American, Latina, Asian, and Caucasian
members. Our program fulfills all four goals of the NHLBI Strategic Vision by: a) elucidating a
new exosomal aspect of human biology; b) reducing human disease by new therapeutic
development against the exosomal pathway; c) developing a work force and an animal model
exosome resource and; d) translating the exosome research to human disease.

Public health relevance
PROJECT NARRATIVE This project describes a new extracellular entity, the pathogen exosome. In diseases such as COPD this type of exosome drives chronic inflammation, tissue damage, and cell death. A complete understanding of the pathogenic exosome may lead to new diagnostics and therapeutics for chronic inflammatory diseases such as COPD.